Dissecting the intrinsic and extrinsic regulators of prostate cancer dormancy in the bonemicroenvironment.

Project Summary / Abstract………………………………………………………………………………..….
Metastatic prostate cancer (PC) typically manifests in the skeleton. The lesions arise from disseminated
tumor cells (DTCs) that often persist in a dormant state for months to decades after initial primary tumor
treatment. Despite our knowledge that DTCs give rise to incurable bone metastatic PC, there remains
gaps in our understanding as to the molecular mechanisms underpinning entry and reawakening from
the dormancy program. Insight into those mechanisms could yield new therapeutic approaches that
would prevent the metastatic relapse and ultimately death of almost 34,500 American men each year.
To address this, we have developed a novel model of PC dormancy in agreement with published
markers in the literature in vitro and optimized a surgical technique to study dormancy in vivo. We next
performed transcriptomic sequencing on PC cells growing under normal, dormant, or reawakening
conditions. Bioinformatic analysis of transcript expression and transcription factor (TF) activity revealed
positive regulatory domain zinc finger region protein 16 (PRDM16) to significantly increase during entry
into dormancy and decrease during exit across mouse (RM1) and human sensitive / castrate resistance
cell lines (LAPC4, 22Rv1). Further, we validated PRDM16 upregulation in dormant cells on the protein
level both in vitro and in vivo. Genetic silencing of PRDM16 led to a significant reduction in the ability
of PC cells to enter dormancy concomitant with decreased expression of anti-apoptotic proteins
including BCL-2 and increased pro-apoptotic proteins such as BIM & Noxa. Preliminary data shows
that PRDM16 expression in PC cells can be induced by BMP-7 and conversely decreased by the BMP
signaling antagonist, noggin, factors with known critical roles in regulating bone homeostasis. Based
on our findings, we hypothesize that BMP7 induces PRDM16 expression in early skeletal DTCs,
which is critical for the initiation of the dormancy program.
In the F99 phase, we will identify PRDM16 transcriptome in PC dormancy and confirm BMP
signaling control on its expression using genetic approaches and validation of findings in pre-clinical
models. In K00 phase, we will study how aging contribute to the reawakening of dormant cancer cells
in the bone microenvironment. We will identify biological and molecular determinants of cancer
dormancy using Cherry-niche technology and comprehensive fluorescence-activated cell sorting
(FACS), high dimensional mass cytometry, and single cell RNASeq experiments. We will then validate
our findings in pre-clinical models and patient tissue sections. Findings from this work will advance our
understanding of the intrinsic and extrinsic factors regulating the cancer dormancy program in skeletal
metastasis in the context of aging, which is relevant to most prostate cancer patients.

Public health relevance
Project Narrative.………………………………………………………………………………………………. Metastasis remains to be the leading cause of cancer death worldwide including metastatic prostate cancer, which poses poor prognosis for patients diagnosed with it. Understanding how cancer intrinsic signaling, metastatic tissue biological players, and aging contribute to dormancy and reawakening is paramount to improving treatment strategies to control metastasis and extend patients overall survival rates. This research proposal will identify intrinsic and extrinsic regulators of skeletal prostate cancer dormancy in the context of aging to provide a better understanding of skeletal metastasis initiation.